HARNESSING IN VIVO CLICK CHEMISTRY FOR 211AT-BASED PRETARGETED RADIOIMMUNOTHERAPY

PROJECT SUMMARY/ABSTRACT
Over the last fifteen years, radioimmunotherapy (RIT) using antibodies labeled with a-emitting radionuclides
has shown significant promise for the treatment of cancer. Yet the the multi-day circulation time of monoclonal
antibodies means that they must be labeled with an a-emitting radionuclide with a multi-day physical half-life:
225Ac (t1/2 ~ 9.9 d). This unavoidable combination of long biological and physical half-lives can create high
radiation dose rates to healthy tissues, a complication that has hampered the clinical proliferation of 225Ac-labeled
radioimmunoconjugates. One approach to circumventing this issue lies in pretargeted radioimmunotherapy
(PRIT). PRIT is predicated on decoupling the immunoglobulin and radionuclide, injecting the former prior to the
latter, and empowering them to recombine at target sites within the body. Labeling the antibody with a fast-
moving, small molecule radioligand after it has reached an optimal biodistribution in vivo limits the circulation
time of the assembled radioimmunoconjugate in the blood and enables the use of radionuclides with half-lives
that are normally incompatible with full-length IgGs. As a result, this approach can produce high activity
concentrations in target tissues at only a fraction of the radiation dose to healthy organs produced by traditional,
directly-labeled radioimmunoconjugates.
This F31 proposal is focused upon creating a novel approach to PRIT that leverages the short-lived, a-
emitting radiohalogen astatine-211 (211At; t1/2 ~ 7.2 h) and the in vivo bioorthogonal click ligation between
tetrazine (Tz) and trans-cylooctene (TCO). To this end, we will employ a proof-of-concept model system based
on the A33 antigen-targeting huA33 antibody as well as murine models of colorectal carcinoma. Specific Aim 1
(SA1) will be focused on the synthesis, characterization, and in vivo evaluation of a library of Tz radioligands
labeled with iodine-131 (t1/2 ~ 8.0 d), an inexpensive surrogate for 211At. In Specific Aim 2 (SA2), we will create
211At-labeled variants of the four most promising radioligands identified in SA1. We will then use these 211At-
labeled tetrazines and huA33-TCO to perform pretargeted biodistribution studies in a subcutaneous xenograft
model of colorectal carcinoma. These biodistribution data will be used to assess the performance of in vivo
pretargeting with each 211At-Tz and enable dosimetry calculations designed to elucidate the radiation dose of
each strategy to tumor tissue and healthy organs. Finally, Specific Aim 3 (SA3) will be centered on validating
the therapeutic efficacy of this approach to 211At-PRIT in subcutaneous, orthotopic, and patient-derived xenograft
models of human colorectal carcinoma. Longitudinal PRIT studies will performed with the two most promising
211At-Tz radioligands from SA2 in order to identify a single construct suitable for clinical translation. In the near
term, this investigation could lead to the creation of a safer and more effective treatment modality for patients
with colorectal cancer. And in the long term, this work could help usher in an era in which 211At-based
radiopharmaceuticals play a vital role in the endoradiotherapy of patients with a wide variety of malignancies.

Public health relevance
PROJECT NARRATIVE Antibodies labeled with alpha particle-emitting radionuclides have shown considerable promise for the targeted radiotherapy of several cancers; however, the clinical implementation of these radiopharmaceuticals has been hampered by concerns over the radiation doses they inadvertently deliver to healthy tissues. Herein, we propose to harness the alpha particle-emitting radionuclide astatine-211 and an extraordinarily selective and rapid chemical ligation to create a new approach to endoradiotherapy capable of delivering high concentrations of radioactivity to tumor tissue while keeping radiation doses to healthy tissues very low. Ultimately, we believe that the clinical translation of this strategy could improve outcomes for patients with a wide variety of malignancies.